The adverse chronic effects of e-cigarettes: puff profiles, sex, genetics, and flavorings as modifying factors

Abstract
Electronic cigarettes (e-cigs), were introduced to the U.S. market only 10 years ago and are markedly
different from traditional tobacco-based cigarettes. Whereas traditional cigarettes are smoked through
combustion, e-cigarettes are “vaped” (i.e., heated), and the resultant aerosols contain a far smaller number of
potentially toxic chemicals, such as nicotine and flavorings (e.g., cinnamaldehyde and diacetyl), as well as
byproducts (e.g., acrolein and formaldehyde) caused by the potential overheating of these agents, propylene
glycol, and glycerin. Thus, although e-cigarettes are widely believed and marketed as a safer alternative to
cigarette smoking, the actual danger posed by its use remains largely unexplored. As the use of e-cigs
steadily rises, the number of health effects studies is still relatively small and have focused on short term
effects. These studies, however, have demonstrated adverse pulmonary and cardiovascular effects in human
subjects and test animals. To date, some long term human health effects studies have investigated e-
cigarettes as cessation devices, but such epidemiology studies are confounded by the `poly-use' of e-
cigarettes and previous (and possibly concurrent) traditional tobacco cigarettes. Therefore, the studies
proposed in this grant application will avoid this confounding and utilize established animal models, previously
used in long-term tobacco studies, to investigate the adverse cardiopulmonary effects of e-cigarettes after
chronic inhalation exposures. In particular, the proposed experiments are designed to discern: 1) the toxicity of
the e-liquid aerosols themselves, with and without added flavorings, generated at different voltages (i.e.
heating coil temperatures); and 2) the contribution of innate modifying factors, such as sex, glutathione
biomarkers and pathways, and genetics, to e-cigarette toxicity. We will test the overall hypothesis that chronic
exposure to e-cigarette aerosols produces adverse cardiopulmonary effects and that these effects are modified
by innate factors, such as genetic heterogeneity and sex (i.e., gender), and exogenous factors, such as
flavorings and e-cigarette coil temperature.

Public health relevance
Narrative: E-cigarettes are widely believed and marketed as a safer alternative to cigarette smoking, yet the actual danger posed by the long term use of these agents remains largely unexplored. The proposed research will use well established animal models to determine the adverse chronic cardiopulmonary effects produced by exposure to e-cigarette aerosols and whether innate factors, such as genetics and sex, or exogenous factors, such as e-liquid flavorings and puff profiles, modify these cardiopulmonary effects.